New Agents for the Treatment on Mycobacteria Avium Infections

Abstract: Non-Tuberculosis Mycobacteria (NTM) are responsible for widespread, life threatening infections
of the lungs, skin, lymphatic and hematological systems. The rapid, global spread of resistant organisms has
significantly reduced the number of agents that can be used effectively to treat these infections. Of specific
clinical relevance are the slow-growing Mycobacterium avium complex (MAC) comprised of M. avium, M.
intracellulare and M. chimaera. MACs are widely distributed throughout the environment, often found in soil,
water and airborne particulates. Mycobacterial infections are a growing cause of concern in
immunocompromised individuals with underlying comorbidities and represent a significant threat as opportunistic
pathogens. Over the past three decades, the incidence of infections caused by MAC NTMs have increased more
than 30-fold. Change in the world climate is allowing these once-unknown environmental mycobacteria to flourish
and establish themselves as an increasingly common source of deadly infections, accounting for approximately
40% of the pulmonary infections (NTM lung disease) found in immunocompromised patients. Currently in the
United States, the prevalence of MAC NTM infections is approximately 50 per 100,000 population, equating to
more than 200,000 new cases annually. It is estimated that this number will grow at a rate of +8% per year. The
costs associated with treatment of NTM-related infections exceeded $800M in 2018.
MAC NTM-LD represents an unmet clinical need as there are few safe and effective drugs available to combat
the infections they cause. Furthermore, because standard antibiotics have so much environmental exposure,
many MAC isolates are natively drug resistant. QMD is focused on the development of an inhaled therapeutic
that inhibits the essential NTM enzyme dihydrofolate reductase (DHFR), which is involved in the biosynthesis of
the nucleic acid building blocks that are a key player in the folate cycle and a validated antibiotic drug target.

Public health relevance
PUBLIC HEALTH RELEVANCE: Mycobacterium avium complex (MAC), a subset of non-tuberculosis mycobacteria (NTM), are responsible for more than 200,000 life threatening pulmonary infections (NTM Lung disease or NTM-LD) each year, particularly in immunocompromised patients. The goal of this grant is to develop a new antifolate as an inhaled alternative for the treatment of NTM-LD infections.